A: Administrative

ABSTRACT
The UW/Fred Hutch CFAR Administrative Core leads the CFAR and is responsible for strategic planning and
operational management. The Aims of the Administrative Core are to: 1) LEADERSHIP: Create and support
a strategic vision with that centers equity, diversity and inclusion (EDI) and fosters a multidisciplinary,
collaborative environment, to facilitate the best science and growth of the next generation of diverse HIV
researchers, both which will impact the global HIV epidemic; and 2) MANAGEMENT: Deliver efficient,
effective, timely, compliant, and collegial operational management to add value to the HIV research
enterprise at our CFAR. These aims will be actualized through the following objectives: 1a) Support our Cores,
SWGs, and partners and reach across disciplines and institutions through convening activities; 1b) Implement
and continuously refine our CFAR strategic plan; 1c) Create an environment to grow collaboration and respond
to emerging needs, opportunities, and scientific priorities; 1d) Foster bidirectional, trusting and robust community
engagement across our CFAR; 1e) Promote equity, diversity, and inclusion (EDI) across the CFAR by
implementing our EDI plan; 2a) Manage the CFAR and its grant, finances, and personnel according to robust
and equitable principles, policies, and procedures; 2b) Grow funding, facilities, and other resources for HIV
research; and 2c) Effectively advertise and promote utilization of CFAR services by ensuring effective
communication systems, promoting engagement and collaboration across researchers, trainees, and the
community. The Core works across our collaborating institutions to achieve these goals, including with: the
President, Provost, and Dean of the School of Medicine at the University of Washington (UW), the President of
the Fred Hutchinson Cancer Center, and CEOs of affiliated institutions, obtaining substantial institutional
commitment of funding and space to grow the work of the CFAR; the UW Department of Global Health, where
the Administrative Core is based, to facilitate and leverage efficient and effective grant administration and
operational support for our investigators; research centers and institutes within our organizations, to catalyze
new research and support robust existing programs; local, state, and federal agencies, and international
partners, to achieve impact at scale in the prevention and treatment of HIV; community-based organizations for
collaborative leadership and engagement; and with other CFARs to synergize with the larger CFAR mission.
Key innovations in the Administrative Core for this proposed cycle include our new Director and restructured
Leadership Team which includes our Directors of EDI and Office of Community Engagement (OCE),
implementation of our new EDI plan and a new strategy for incorporating community engagement across our
CFAR, incorporating ESIs into Core and SWG leadership, and substantial institutional commitment to meet
CFAR aims. Our Administrative Core will provide effective, efficient, and strategic leadership and management
to support our CFAR in achieving its mission.